Bioinformatics

ABSTRACT, Cancer Bioinformatics Core (CBC)
The Cancer Bioinformatics Core (CBC) at Indiana University Melvin and Simon Cancer Center (IUSCC) was
established during the last funding cycle. The IUSCC Executive Committee and Leadership Council identified
the need for increased and robust bioinformatics services for IUSCC members. The Core operates and focuses
on supporting the increasing needs from IUSCC members for bioinformatics analyses, including Next Generation
Sequencing (NGS) and diverse `omics' data. Responsive to IUSCC investigators' special requests the Core
performs in-depth data mining and comprehensive analyses on public domain data [e.g. datasets from The
Cancer Genome Atlas (TCGA)]. The CBC service includes but is not limited to RNA-seq, ChIP-seq, whole
genome bisulfite sequencing, whole exome/genome sequencing, ATAC-seq (assay for transposase-accessible
chromatin), proteome and other analyses. The Core has been working intimately with other shared facilities in
the IUSCC, e.g. Genomics Core, Proteomics Core, and Biostatistics and Data Management, to successfully offer
in-depth, collaborative level, and comprehensive bioinformatics services for IUSCC members on experimental
designs, data collection, processing, and analyses. The CBC is dedicated to providing the highest quality service
to IUSCC research community. The goal of the CBC is to integrate all available data achieved by advanced
technologies to accelerate cancer discovery, drug discovery, precision medicine and bioinformatics training. The
Core incorporates expertise from bioinformatics, molecular genetics and genomics to enhance research
capability serving as the foundation for data generation and analyses to support cancer research projects in the
IUSCC. Under the senior leadership of the IUSCC, the Core developed robust strategic plan to advance each
Research Program with strong and specific bioinformatics support.